COmparing iNoTRope prACtice variaTION in Cardiac Surgery (CONTRACTION-CS)

Abstract
Cardiac inotrope medications used to augment heart contractility during recovery from cardiac surgery carry
steep tradeoffs between risks (e.g., myocardial ischemia, malignant arrhythmia) and benefits (e.g., enhanced
perfusion to vital organs). Inotrope use is often locally standardized within hospitals based on institutional
preferences, rather than individualized to patient-specific risks and benefits. While inotropes are necessary for a
minority of patients with advanced cardiogenic shock to survive past the operating room, on average, inotropes
are independently associated with 3-fold increased mortality (absolute rate 5.0%) and major complications
(18%). For the majority of the 300,000 US patients undergoing cardiac surgeries each year, limited evidence
exists to support or refute the ability of inotropes to improve outcomes. As a result, inotrope practice patterns
vary widely across institutions, contributing to wide variation in rates of mortality and complications.
There is a critical need to understand inotrope use in modern, generalizable cardiac surgery populations, and
identify patient-specific contexts in which inotropes are helpful versus harmful. Without such information,
unwarranted variation in inotrope use for cardiac surgery will remain high, and opportunities to reduce risk of
major complications related to their use (or non-use) will be missed. A paradigm shift to address this need
remains possible through (i) availability of preoperative patient risk factor data, detailed minute-to-minute
perioperative data, and high-quality outcomes registry data; and (ii) channels to access frontline clinicians
capable of describing local practice patterns, structural factors, and attitudes towards inotrope use. Such an
understanding requires integration of multicenter cardiac surgery research and quality collaboratives to validate
findings in a large, contemporary cardiac surgical cohort, while engaging clinician stakeholders in the process.
We propose a multicenter study which leverages the integration of two unique, mature research and quality
improvement collaboratives built upon standardized national registries: the Multicenter Perioperative Outcomes
Group (MPOG) and the Society for Thoracic Surgeons (STS) Adult Cardiac Surgical Database. MPOG uses
nurse-validated, detailed minute-to-minute intraoperative and early ICU data from the EHR for research and
quality improvement. With University of Michigan as the Coordinating Center and guided by Research Director
PI Mathis, MPOG has integrated over 21 million patient records across >40 health systems in 23 states and
provides quality improvement feedback reports to >7,000 frontline anesthesiology clinicians. In addition, MPOG
has integrated each member hospital’s STS clinical registry to create a unique national “MPOG-STS” dataset.
We will (i) identify patient, clinician, and institution phenotypes associated with inotrope practice patterns (choice,
timing) in cardiac surgery; (ii) characterize and quantify institutional barriers to inotrope practice change; and (iii)
estimate context-specific causal effects of inotropes on outcomes through a novel integration of cardiac surgical
databases, which address unmeasured confounders that have historically biased previous observational studies.

Public health relevance
Narrative (Public Relevance Statement) Cardiac inotrope medications used to augment heart contractility during recovery from cardiac surgery carry steep tradeoffs between risks (e.g., myocardial ischemia, malignant arrhythmia) and benefits (e.g., enhanced perfusion to vital organs), and are independently associated with 3-fold increased mortality and complication rates. Aside from patients with advanced cardiogenic shock wherein inotropes are necessary for survival past the operating room, limited evidence exists to support the ability of inotropes to improve survival or reduce complications among the majority of 300,000 patients undergoing cardiac surgery each year, and as a result, inotrope practice patterns vary widely across clinicians and hospitals, contributing to wide variation in mortality and major complication rates. We seek to (i) identify patient, clinician, and institution phenotypes associated with inotrope practice patterns; (ii) characterize and quantify institutional barriers to inotrope practice change; and (iii) estimate context-specific causal effects of inotropes on outcomes through a novel integration of cardiac surgical databases which address unmeasured confounders historically biasing previous observational studies.